The Effect of Prenatal and Postnatal Adversity on Neurodevelopment and Behavioral Functioning

Project Summary/Abstract
Very little is known about the joint effects of prenatal alcohol exposure (PAE) and childhood adversity. PAE acts
as a disruptor to prenatal development and is known to impact postnatal development, as seen through
structural brain changes, cognitive deficits, and behavioral symptoms. Compared to individuals without PAE,
children with PAE have been studied to have smaller overall brain volume with regions such as the corpus
callosum, basal ganglia, and cerebellum particularly affected. These differences are reflected in
neurobehavioral symptoms, such as deficits in executive functioning and externalizing behaviors (e.g.,
aggression, hyperactivity, and conduct problems) that are seen through adulthood. Therefore, the
consequences of PAE have a significant impact on lifelong well-being, and with high rates of misdiagnosis,
PAE is a great public health concern. Similarly, childhood adversity, characterized through adverse childhood
experiences (ACEs), also disrupts typical neurodevelopment, and differences are seen in the amygdala,
prefrontal cortex, and hippocampus. In consequence, childhood adversity is related to cognitive deficits and
elevated externalizing and problem behaviors across the lifespan. Despite the similar behavioral impacts of
PAE and ACEs and their high rates of co-occurrence, little research has been done to observe the neurological
impacts of both, especially in adulthood. The need for this research is vital because it may result in a more
accurate portrayal of symptoms that individuals with PAE are experiencing. Therefore, there is a significant
need for research in this area to understand the underlying neurodevelopmental processes associated with
PAE and ACEs that then result in cognitive and behavioral difficulties. Furthermore, these externalizing
behaviors have the potential to affect daily functioning, severely impacting well-being in adulthood. Childhood
adversity has been associated with an increased risk of contact with the justice system, and PAE has been
associated with increased delinquency as well in other countries (i.e., Canada, Australia). Therefore, there is a
need to better understand if the joint impact of PAE and ACEs may increase justice system involvement in the
United States. This proposed project will fill a gap in the research as it will (1) assess the joint impact of PAE
and ACEs on neurodevelopment and consequent neurobehavioral outcomes and (2) study how the
neurodevelopmental and behavioral outcomes from PAE and childhood adversity can increase the likelihood of
trouble with the law.

Public health relevance
Project Narrative Prenatal alcohol exposure and childhood adversity both act as adverse factors that disrupt typical neurodevelopment. In turn, these prenatal and postnatal adverse experiences affect cognitive and behavioral outcomes, resulting in cognitive deficits and externalizing behaviors that are related to an increased risk of criminal behavior. This proposed research aims to understand the underlying neurodevelopmental processes caused by the dual impact of prenatal alcohol exposure and childhood adversity and how this joint impact can increase the likelihood of trouble with the law.